In vivo MRI Measures of Brain Metabolism in Traumatic Brain Injury

PROJECT SUMMARY
Traumatic brain injury (TBI) represents a major public health concern in the United States. TBI can result in
long-term neurological complications, including neurodegeneration, behavioral dysfunction, depression and
epilepsy that seriously affect patient quality-of-life. Brain glucose utilization has been found decreased in 60%
of patients with chronic TBI and is one of the prognostic indicators for the long-term outcome of TBI. Both
animal and human studies have identified that the neurovascular uncoupling between cerebral blood flow
(CBF) and brain tissue energy demands is a key factor for cerebral metabolic crisis in the TBI brain. The
neurovascular uncoupling results in energy mismatch that disrupts normal neuroglial function and arrests
repairing process. Despite numerous clinical trials on potential therapies, there is no U.S. Food and Drug
Administration approved drug therapy for the treatment of TBI. One of the reason clinical trials failed is due to
the inability that can accurately evaluate the region-specific perturbations of brain glucose metabolism and
determine if a treatment can restore neurovascular coupling in the TBI brain. Existent glucose measuring
techniques, including microdialysis, continuing blood glucose monitoring, spectroscopy, or positron emission
tomography (PET) which uses tracer radioisotopes, provide insufficient resolution to determine region-specific
glucose utilization in the brain. In this proposal, we determine to assess the utility of a novel MRI-based
Chemical Exchange Saturation Transfer (CEST) imaging, to provide the needed high-resolution for measuring
region-specific metabolism for TBI. The glucose detecting CEST MRI (glucoCEST) measures brain glucose by
detecting the exchangeable proton signals of glucose without using radioisotopes and generates glucose
mapping in a resolution >100 times higher than PET scans. Our preliminary and published data have
demonstrated that glucoCEST may be feasible to detect the delayed hypometabolism of diffuse TBI in rats. We
propose to combine high-resolution glucoCEST and the Dynamic Contrast Enhanced (DCE) perfusion MRI for
concomitant CBF measurements to identify the neurovascular coupling state following TBI over time. Our aims
are designed to (1) Identify the contrast mechanism of in vivo glucoCEST in the TBI brain to enhance the
sensitivity and specificity of glucoCEST with advanced acquisition scheme and analytical models, (2)
Characterize perturbations in brain glucose metabolism and perfusion deficits in the TBI brain, and (3)
Demonstrate the potential application of the dual-modality CEST-DCE MRI to noninvasively monitor the
treatment effects of a clinically-recommended intervention for TBI. Overall, these studies will provide a strong
technical and scientific foundation to move the field forward in utilization of advanced MRI for personalized
care in the clinical arena and determine the best treatment strategy for the brain injured patients.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance Statement) Traumatic brain injury (TBI) perturbs the glucose metabolism of the brain and causes energy crisis that accelerates the development of neurodegenerative diseases in needs of a sensitive imaging tool for diagnosis and prognosis. This project introduces a novel glucose detecting CEST MRI to obtain brain glucose images with resolution ~100 times greater than the current PET images to assist clinicians in determining the best treatments for TBI. We still utilize CEST MRI, in concert with multiple advanced MRIs on a rat model of TBI, to evaluate the treatments of neurological impairments in associated with the disruptions of glucose metabolism.